Refinement of Very Low Leakage Non-Invasive Ventilation Mask for Infectious Patients

PROJECT SUMMARY/ABSTRACT
A large number of patients with infectious respiratory diseases such as COVID-19, influenza, and SARS
require respiratory support. Noninvasive Positive Pressure Ventilation (NPPV) via a mask is an appropriate
treatment for many patients that can lead to better outcomes than intubation. Additionally, the equipment used
for NPPV (such as CPAP machines) is widely available, making NPPV well suited for responding to outbreaks
and pandemics. Unfortunately, NPPV masks increase the risk of disease transmission by spreading
contaminated aerosols leaking from the mask seal. This exposes health care workers and other patients to
increased risk and can hamper efforts to contain outbreaks of infectious diseases. The objective of this program
is to develop an innovative NPPV patient interface that greatly reduces the leakage of contaminated aerosols
through the mask seal. The two key innovations are a purged dual seal and a mask integrated vacuum ejector.
The dual seal captures contaminated leakage across the primary mask seal and integrated ejector provides the
purge flow required by the dual seal. All the contaminated flow is then passed through to a viral filter before
exhausting to the room. Our device is a cost effective drop in replacement for existing masks that integrates
easily with NPPV equipment used in hospitals.
In a prior program and Phase I, we developed and tested initial PDS mask prototypes. We demonstrated
far better sealing performance than a leading commercial mask in laboratory and human subject testing. In the
proposed Phase II program we will refine and productize our mask design, extensively test the performance,
publicize the results, and prepare for regulatory clearance and commercialization. This will enable our innovative
leak-prevention mask technology to be widely deployed in critical care settings—benefiting patients and
protecting health care workers.

Public health relevance
PROJECT NARRATIVE The treatment of infectious patients (such as those with COVID-19 and influenza) with Noninvasive Positive Pressure Ventilation (NPPV) currently poses a risk of spreading the disease through mask leakage. The device developed in this project will enable NPPV treatment with virtually no mask leakage and greatly reduced risk. This will enable widespread use of this effective treatment on infectious patients while protecting health care workers and other patients.